CK22-005 - CDC Southeastern Center of Excellence in Vector-Borne Diseases: Gateway Program

This is a renewal application for the CDC Southeastern Center of Excellence in Vector-Borne Diseases: Gateway
Program (SECVBD) led by the University of Florida with both well-established and burgeoning collaborations
with 13 universities with strong vector biology programs across the Southeastern United States (U.S.) and Puerto
Rico. This integrated academic network carries the full and integrated support of state departments of health,
state and federal agricultural agencies, U.S. military programs, national and international associations, and >60
local mosquito and vector control programs. Our proposal leverages the expertise across a broad remit of basic
and applied vector biology as well as epidemiological disciplines to continue to maintain the success of our
program in (i) establishing an integrated community of practice in public health entomology consisting of
academic institutions throughout the Southeast and local, state, and federal public health agencies, to facilitate
existing and future efforts in vector-borne disease (VBD) surveillance and control and (ii) expanding an effective
academic, online, and internship-based training program in basic public health entomology to augment the cohort
of personnel who are trained with the requisite knowledge and skills to quickly detect and respond to VBDs
across the U.S., and (iii) initiating the drive towards an evidence-based set of recommendations and a tailored
template of a “surveillance-response program” to ensure that local mosquito and vector control associations can
better monitor and control VBDs in the U.S. For the next iteration of the SECVBD, we take advantage of the
biocomplexity of tick- and mosquito-borne diseases in the Southeastern U.S. and Puerto Rico and leverage an
integrated, data-driven, applied research program designed to produce maximal output in novel interventions
and training paradigms within a 5-year period to tackle the following CDC priorities: (a) Laboratory/field
evaluations of emerging technologies to suppress host-seeking ticks or disrupt pathogen transmission cycles;
(b) Field studies aimed at optimizing application of tick control products to provide recommendations for pest
control firms and homeowners regarding how to optimize tick suppression; (c) Assessments of the potential for
incorporating tick management into existing mosquito management programs; (d) Investigations on the
knowledge, attitudes, & behaviors regarding tick control methodologies, (e) Evaluation of the impact of existing
public education programs on TBI risk & behaviors to prevent tick bite; (f) Field evaluations of emerging
technologies to suppress mosquito adults (insecticide resistance); (g) Field evaluations of mosquito management
approaches based on commercially available methods and products (both entomological and human-related
outcome measures); and (h) Evaluations of the effectiveness of operational control activities targeting all
mosquito stages (including insecticide resistance). The goal is to maintain our established, comprehensive,
applied, and basic research program to further our understanding of VBD transmission to prevent VBDs in the
continental U.S. and territories.

Public health relevance
The goal of the CDC Southeastern Center of Excellence in Vector-Borne Diseases: Gateway Program (SECVBD) is to maintain our established, comprehensive, applied, and basic research program that fully addresses the epidemiological triad to underpin our understanding of vector-borne disease transmission in the continental U.S. and territories. The SECVBD’s primary Public Health Outcomes include: (i) Diversity, equity, and inclusion (DEI) in accessing training opportunities in public health entomology (PHE); (ii) Higher resolution of tick vector distribution and tick-borne illness (TBI) prevalence in vector populations; (iii) Enhanced vector surveillance and control operations; (iv) Strengthened PHE Community of Practice in the Southeastern U.S. and U.S. Territories in the Caribbean; (v) Exploration of strategies for proactive vector control; (vi) New delivery modalities for novel chemical active adulticides against insecticide-resistant mosquitoes; and (vii) Socio- behavioral modifications viz. clinical TBI diagnoses, personal protective measures, and adoption of tick- encounter reduction technology.